CORE--ELECTRON MICROSCOPY

DESCRIPTION (provided by applicant): The Electron Microscopy Facility provides a wide range of specialized services for electron microscopy and quantitative image analysis to members of the University of Chicago Cancer Research Center. Services range from negative stain analysis of single molecules and macromolecular assemblies, through transmission EM of cells and tissues, to scanning electron microscopy of embryos and whole mount specimens. The facility specializes in the immunogold localization of molecules, utilizing either frozen thin sectioning of aqueous samples, or freeze substitution of Lowicryl-embedded samples. The EM facility is equipped with both transmission and scanning electron microscopes, together with all the necessary ancillary equipment for the full range of EM services. In collaboration with the Digestive Disease Center EM facility operated by Dr. Robert Josephs, structural analysis of individual molecules is available using a cold transfer stage for viewing specimens at -170oC. Full time assistance is available for specimen preparation, microscopy, photographic imaging, quantitative image analysis and preparation of results for publication. Expert consultation is also available for project planning and data analysis. User services are coordinated with the UCCRC Digital Light Microscopy facility to provide integrated support for light and electron microscopy based research.